Early Life Predictors of Airway to Lung Dysanapsis

PROJECT SUMMARY/ABSTRACT
Chronic obstructive pulmonary disease (COPD) accounts for 6% of all deaths worldwide and is potentially
preventable, with well-described but poorly elucidated childhood origins. Our research team recently identified
that the mismatch between airway tree caliber and lung volume that arises early in life, dysanapsis, is: 1)
prevalent among older adults when measured by computed tomography (CT), 2) is a major predictor of COPD
risk – exceeding tobacco smoke and other established risk factors, and 3) is not fully explained by genetics. We
also know that there are heterogenous structural presentations of dysanapsis. Variation in dysanapsis, and
COPD risk, may have early life, environmental causes. Research has revealed that two early risk factors,
obesity and viral respiratory infections, contribute to two distinct subtypes of dysanapsis that have yet to be
examined. Several studies have also examined the impact of early-life air pollution exposure on lung function
and growth, with limited generalizability due to the use of racially/ethnically homogenous populations and not
accounting for neighborhood-level social factors as effect modifiers.
This R01 study will leverage 8 longitudinal birth cohorts of diverse children to examine the relationship
between early-life exposures and both the structural (imaging-assessed) and functional (spirometry-
assessed) determinants of dysanapsis throughout childhood and adolescence to identify modifiable risk
factors and help reduce risk of COPD in future generations at risk. Building on our preliminary data showing
that magnetic resonance imaging (MRI) is as accurate as CT at identifying dysanapsis, we will integrate state-
of-the-art lung MRI data with extensive early-life exposure and lung function data. Aim 1 will establish
relationships between early life dysanapsis (functionally-confirmed) and childhood lung function trajectories, and
their relationship to dysanapsis (functionally- and structurally-confirmed) at late adolescence. Aim 2 will
determine if obesity and viral infections contribute to distinct structural subtypes of dysanapsis (structurally-
confirmed). Aim 3 will examine early life air pollution exposures and neighborhood social factors association with
dysanapsis (functionally-confirmed) in diverse cohorts of children. This study aligns with NHLBI's strategic
objective to investigate factors accounting for health differences among populations. We will establish the early
life risk factors that contribute to airway-to-lung phenotypes and enhance our understanding of the utility of both
structural- and functional-based measures of dysanapsis. Ultimately, our findings will inform targeted
interventions to high-risk groups of children to reduce their subsequent risk of COPD.

Public health relevance
PROJECT NARRATIVE Dysanapsis, the mismatch between airway tree and lung size, is a common structural variation in the lung that is a better predictor of chronic obstructive pulmonary disease than smoking and all previously described risk factors. In this R01 study, our objective is to examine the relationship between early-life exposures and both structural (lung MRI-assessed) and functional (spirometry-assessed) measures of dysanapsis throughout childhood and adolescence. We will leverage 8 longitudinal birth cohorts of diverse children to identify modifiable risk factors for dysanapsis and help reduce risk of COPD in future generations at risk.